Vascular Reactivity to Compounding Stressors across the Blood Alcohol Curve: Interactions with Chronic Drinking and Polysubstance Use

PROJECT SUMMARY/ABSTRACT
Despite national health guidelines and the prevalence of alcohol-related cardiovascular disease, alcohol
remains among the most popular recreational substances misused across the lifespan. Drinking behaviors are
often initiated in early adulthood and, in the absence of overt illness or diagnosis of an alcohol use disorder
(AUD), may be maintained for decades. Such drinking often occurs on a backdrop of chronic stress, even in
ostensibly healthy young adults. Further, recent societal shifts in perspectives and laws surrounding
recreational cannabis use have encouraged open positivity around alcohol co-use behaviors, even in otherwise
health-conscious individuals. A critical public health problem in fighting cardiovascular disease is that alcohol-
related physical health deterioration is insidious, evolving slowly as the result of chronic allostatic pressure
placed on organ systems by alcohol in combination with other lifestyle factors. Alcohol acutely elicits both
vasodilation and vasoconstriction that undoubtedly amplifies tension on the vasculature; yet, symptoms of
vascular injury (e.g., coronary artery disease) are often hidden until >90% vessel occlusion. This makes it
difficult for most people to ‘connect’ health behaviors, like alcohol consumption, to vascular degeneration. This
application proposes that identification of early biomarkers of alcohol’s effects on the vasculature are critically
needed to lower the prevalence of alcohol-related cardiovascular disease. The NIAAA F31 application
proposes a novel study design and analytical approach to unravel individualized vascular dynamics across the
blood alcohol concentration (BAC) curve in relation to chronic alcohol use behaviors (Research Aim 1), a
concurrent acute stressor (Research Aim 2), and alcohol/cannabis co-use behaviors (Research Aim 3). The
single-session alcohol administration study of chronic binge versus non-binge drinkers incorporates a periodic
isometric handgrip task, an acute vascular challenge that can magnify vascular responses, during peak
intoxication and recovery to evaluate adaptive potential. Recent cannabis use, measured from urinary THC
metabolite concentration, on vascular responsivity will be also explored. A multilevel mixed modeling approach
will capture changes in continuous blood pressure during the alcohol challenge alone and during the grip tasks.
This research study will be supported by extensive training in alcohol studies, with a focus on pharmacological
effects of alcohol (Training Goal 1), alcohol/cannabis interactions (Training Goal 2), cardiovascular physiology
(Training Goal 3), and advanced statistical design (Training Goal 4). Together, the research and training plans
will lay the foundation for the applicant’s future line of research to examine physiological factors that ultimately
contribute to the development of alcohol-related disease across the lifespan. Receiving the NRSA F31
fellowship will relieve the applicant from a time-intensive teaching assistant position to effectively double his
time available to conduct research and establish a strong professional network (Training Goal 5) within the field
of alcohol studies.

Public health relevance
PROJECT NARRATIVE Vascular dysfunction, such as hypertension or atherosclerosis, is a leading cause of death in the United States and linked to heavy drinking behaviors. However, the acute effects of alcohol on vascular functioning are subtle and clouded by chronic cardiovascular loads such as frequent heavy drinking, drug-drug interactions (such as alcohol/cannabis co-use), and chronic stress. This application proposes five training goals and three research aims to launch a unique line of independent research that seeks early signs of vascular dysfunction to reduce alcohol-related cardiovascular disease prevalence.